Portable Microsampling Backpack with Integrated Sensing System

Project Summary
This work aims to create an important sampling tool for the neuroscience research community that will allow for
microsampling within the brain in a completely unrestrained rat. The backpack/sampling system that will be
developed for rats will address a significant capability gap by incorporating portable advanced fluidic handling
platforms useful for neuroscience research. The proposed backpack serves as an initial development platform
to further integrate electrophysiological measurements, optogenetic capability and other chemical sensors.
This research consists of a two-stage objective that (1) aims to develop a portable/backpack sampling platform
for integration with commercial microdialysis probes, and (2) verification of backpack functionality under multiple
sampling conditions to include durability testing, in vivo sampling from the rat brain via coupling to microdialysis
probes, and integration with prototype 3D printed microsampling probes created using two-photon polymerization
stereolithography (Nanoscribe instrument). This backpack will be portable, battery-powered, and includes on-
board data processing, integrated fluid pumping and fluid management, with robust real-time chemical sensing.
The prototype backpacks consist of four key components: (1) custom microcontroller board, (2) fluidic pumping
mechanism, (3) microfluidic chip, and (4) an integrated UV-vis sensor. The goal is to have a closed loop fluidic
system where a pumping mechanism drives fluid through microfluidic channels from the probe to the sensor
array and back to the probe. A secondary goal is to allow for selective off-loading of fluid for quantifying solutes
externally via LC-MS or other methods. Finally, expansion of the pumping mechanism (to multiple pumps) to
allow for use with multiple probes for simultaneous sampling from different brain regions. All these features will
be balanced in size, power, and weight as to allow for sufficiently long sampling times (>5 hours initially) and to
not burden the animal.
The backpack prototypes will be tested using metronidazole, a strongly UV-VIS absorbing drug, as well as
caffeine. Subsequent backpack prototypes with the 3D printed microsampling probes will be used for dopamine
and glutamate detection that will be performed with the off-loading fluidic mechanism. Completion of this
proposed work will lead to an initial portable battery-powered backpack sampling platform that can integrate with
commercial microdialysis probes along with in-house 3D printed probes and serves as a steppingstone for
addition of other sensing or modulating devices.

Public health relevance
Project Narrative A backpack-based device that sits comfortably on the back of a rat is being created that will ultimately allow for brain chemistry measurements in unrestrained rodents. The device includes the necessary pumps and a detector to allow a rat with an implanted microsampling probe to move around completely unrestrained facilitating basic neuroscience research in important areas such as learning and fear-based responses. The device will then be coupled to in-house 3D printed sampling devices that can meet on-demand researchers' needs.